2023 Neuroethology: Behavior, Evolution and Neurobiology Gordon Research Conference and Seminar

Project Summary:
This proposal requests funds to support the 10th Gordon Research Conference (GRC) in Neuroethology, to be
held August 6 - August 11, 2023 at Mount Snow, West Dover Vermont, USA. Funds received from the NIH will
be used solely to defray the travel and registration costs incurred by students, postdocs, and other invited
speakers, with preference being given to early career scientists, women, and members of under-represented
groups in STEM. The GRC will be preceded by a two day Graduate Research Seminar (GRS) organized by a
graduate student and postdoctoral fellow along with invited mentors that are leaders in the field. The GRS
offers graduate students and postdocs an opportunity to present their current research and to build a sense of
community within their field prior to attending the GRC. Together, the GRC and GRS provide unique
opportunities for networking and collaboration.
Central to the BRAIN initiative is a growing appreciation that the neural circuit dynamics that underlie complex
behaviors vary strikingly based on context, and hence studies of natural behaviors in diverse animals are
critical for a meaningful understanding of the neural basis of behavior. Recent cutting-edge methodologies and
computational approaches in neuroethology are revealing how features of individual neurons (e.g.
biochemistry, connectivity) impact circuit function, and how recent history, homeostatic mechanisms, and
energetics shape neural circuit output and hence behavioral performance. The 2023 GRC program
encompasses a multidisciplinary approach to neural circuit computations. The speakers are applying new
technologies in diverse animals to link genes, biochemistry, anatomy, and physiology of cells to emergent
circuit properties. Animals experience varying and unpredictable sensory environments and themselves have
variable experiences and internal states – all of which impact neuron and circuit properties. Neural circuits
have evolved homeostatic mechanisms to buffer variability as well as diverse forms of plasticity to tune
themselves to meet the ongoing needs of the animals. The resulting circuit configurations influence neural
coding and the abilities of animals to perform adaptive behaviors in complex, real world environments.

Public health relevance
Project narrative: The theme of this conference is to determine the biochemical, anatomical, and network properties that shape the dynamic neural circuits underlying sensory-motor behaviors. Funding for conference participants will enable students, postdocs and early faculty to develop new collaborations that will reveal general principles of neural coding that impact treatments for human locomotion, navigation, sensing, and brain and spinal cord dysfunctions. The central theme of the meeting furthers primary goals of the BRAIN initiative: to employ novel neural recording devices and computational principles by which neural circuits operate naturally to generate adaptive behavior.